Mechanisms of cannabinoid tolerance

This study will investigate the mechanisms of cannabinoid tolerance. This objective will be achieved
by determining whether cannabinoid tolerance is mediated through agonist-specific mechanisms
using a model of chemotherapy-induced neuropathic pain. Our approach will examine tolerance to
the anti-allodynic and antinociceptive effects of ∆9-THC, CP55,940, and WIN55,212-2, three
cannabinoid agonists with distinct signaling and chemical features. Tolerance to ∆9-THC
antinociception in the tail-flick test was eliminated by pre-treatment of S426A/S430A mutants with
SP600125, a selective c-Jun N-terminal kinase (JNK) inhibitor suggesting that JNK (SP600125
inhibitor) and GRK/βarrestin2 (S426/S430A mutation) signaling mechanisms coordinate to mediate
tolerance to the antinociceptive effect of ∆9-THC. The first objective of this study is to, fully and
systematically, test the hypothesis that cannabinoid tolerance is mediated through agonist-specific
mechanisms. The second objective is to test the hypothesis that JNK-mediated tolerance for ∆9-THC
requires the presence of β−arrestin2. The third objective is to test the hypothesis that β−arrestin2 and
JNKs can form protein-protein interactions in vivo. The fourth objective is to test the hypothesis that
JNKs can directly phosphorylate CB1 when activated by ∆9-THC using a technologically innovative
chemical-genetic approach. The first three hypotheses will be tested in a clinically relevant model of
chemotherapy (cisplatin)-induced model of neuropathic pain. The last hypothesis is equally
innovative and will provide important information regarding the molecular mechanism of action that
is responsible for JNK-mediated ∆9-THC tolerance. The overarching goal of this project is to gain a
better understanding of the agonist-specific mechanisms responsible for cannabinoid tolerance that
will facilitate the development of long lasting, highly efficacious, and personalized pain therapies.

Public health relevance
One of the primary cannabinoids in cannabis, delta-9-tetrahydrocannabinol (∆9-THC), has been increasingly used by cancer patients for its analgesic properties as well as for the treatment of nausea secondary to cancer chemotherapy. However, tolerance represents a significant disadvantage for cannabinoid therapies and has been demonstrated clinically in heavy use of cannabis prescribed for cancer pain treatment. Successful completion of this research project will address our novel concept that cannabinoid tolerance occurs through agonist-specific mechanisms, providing novel insight about the mechanisms of cannabinoid tolerance and advancing the knowledge base needed to develop improved and innovative therapeutic strategies.